Signaling pathways regulated by GSK3 in hematopoietic stem cell

Principal Investigator/Program Director (Last, First, Middle): Huang, Jian Signaling pathways regulated by GSK3 in hematopoietic stem cells Abstract Hematopoietic stem cells (HSCs) possess two distinct features: the ability to self-renew and to differentiate into mature blood cells. The signaling pathways that regulate HSC self-renewal and differentiation are not well understood. Glycogen synthase kinase-3 (GSK3), a negative regulator of canonical Wnt signaling and a downstream target of hematopoietic growth factor signaling pathways that signal through Jak/Stat and PI3 kinase/Akt dependent pathways, has been implicated in the regulation of HSC activity. Canonical Wnt signaling has been implicated in HSC self-renewal, but the role of this pathway remains controversial. Recently, the PTEN-PI3K-mTOR pathway has been demonstrated to play an essential role in HSC maintenance. Our hypothesis is that GSK3 is a critical effector downstream of Wnt and PI3K within HSCs that regulates the HSC population. In support of this hypothesis, our preliminary data show that: 1) lithium and other selective GSK3 inhibitors significantly increase the number of HSCs in mice, 2) RNAi mediated depletion of Gsk3 in murine HSCs initially expands the HSC population in bone marrow transplants, but long-term inhibition of GSK3 exhausts HSC. 3) The expansion of HSCs by inhibition of GSK3 is mediated through β-catenin while the depletion of HSCs is largely dependent on mTOR signaling. These observations support the hypothesis that GSK3 is an important regulator of hematopoiesis. In this proposal, we will extend our study to explore the functional role of GSK3 phosphorylation in HSCs. We will also address the isoform specific functions of Gsk3a vs Gsk3b in hematopoietic cells with newly constructed conditional knockouts in mice. The non cell- autonomous effect of GSK3 inhibition on HSCs will also be explored with the conditional knockout of Gsk3 in the osteoblast niche. Furthermore, we will test whether modulating the activity of GSK3 and mTOR can expand HSCs in ex vivo culture. A functional screen to identify new regulators of HSCs self-renewal in ex vivo culture will be carried out. The overall goal of this project is to examine the respective contributions of Wnt and PTEN-PI3K-mTOR signaling in the response to GSK3 inhibition and to define the role of GSK3 in regulating these pathways within the hematopoietic system. The knowledge learned from these studies will provide new insights into the mechanisms of the regulation of HSC self-renewal and differentiation and may improve the therapy of hematopoietic disorders. 1

Public health relevance
Project narrative Blood cells arise from a common precursor called the hematopoietic stem cell (HSC), which is able to differentiate into mature blood cells and is also able to replenish the pool of HSCs. Clinically, HSCs are required for bone marrow transplantation to treat leukemia and other diseases of the blood. The long-term goals of this project are to extend our understanding of HSC biology and to improve HSC/bone marrow transplantation. __SpecificAimsTextDelimiter__ Principal Investigator/Program Director (Last, First, Middle): Huang, Jian Signaling pathways regulated by GSK3 in hematopoietic stem cells Specific aims Hematopoietic stem cells (HSCs) have the capability to self-renew and differentiate into all blood cell lineages. The signaling pathways that regulate HSC self-renewal and differentiation are not well understood. Glycogen synthase kinase-3 (GSK3), a negative regulator of canonical Wnt signaling and a downstream target of hematopoietic growth factor signaling pathways that signal through Jak/Stat and PI3 kinase/Akt dependent pathways, has been implicated in the regulation of HSC activity. Canonical Wnt signaling has been implicated in HSC self-renewal, but the role of this pathway remains controversial. Recently, the PTEN-PI3K-mTOR pathway has been demonstrated to play an essential role in HSC maintenance. Our hypothesis is that GSK3 is a critical effector downstream of Wnt and PI3K within HSCs that regulates the HSC population. Our published data using Gsk3 RNAi suggests that GSK3 plays critical roles in HSC and progenitor cell (HSPC) homeostasis. Activation of Wnt signaling by inhibiting GSK3 leads to hyperproliferation of HSCs. However, prolonged inhibition of GSK3 leads to depletion/exhaustion of HSPCs through activation of the mTOR pathway, which can be rescued by the mTOR inhibitor rapamycin. In this proposal, we will extend our study to address whether the phosphorylation of GSK3 is required to regulate HSPCs activity in vivo. We will also further clarify isoform specific cell-autonomous effects of GSK3 knockout on HSCs and explore the non- cell-autonomous hematopoietic effects of GSK3 knockout in the osteoblast niche. Furthermore, we will test whether modulating the activity of GSK3 and mTOR can expand HSCs in ex vivo culture and carry out a functional screen to identify new regulators of HSC self-renewal. The overall goal of this project is to examine the respective contributions of Wnt and PTEN-PI3K-mTOR signaling in the response to GSK3 inhibition and to define the role of GSK3 in regulating these pathways within the hematopoietic system. The knowledge learned from these studies will provide new insights into the mechanisms of the regulation of HSC self-renewal and differentiation and may improve the therapy of hematopoietic disorders. Aims to be completed in K99 period: Specific aim 1: Role of GSK3 phosphorylation in long-term maintenance of HSPCs in vivo: GSK3 activity is inhibited through N-terminal phosphorylation by Akt, which in turn is regulated by PI3K and PTEN. We hypothesize that GSK3 is a critical downstream effector of PTEN (through Akt) and that phosphorylation of GSK3 is important in maintaining homeostasis of HSCs in vivo. To test this hypothesis, we will examine the hematopoietic phenotypes of Gsk3ser21/9ala knockin mice, which lack the Akt phosphorylation sites in GSK-3α and ss, and test whether phosphorylation deficient Gsk3ser21/9ala prevents the myeloproliferative state and leukemia caused by PTEN knockout. Specific aim 2: Examine the in vivo role(s) of GSK3 in HSCs and in the osteoblast niche: Conditional gene knockouts for Gsk3a and Gsk3b will be used to a) confirm RNAi data on the combined roles of Gsk3a and Gsk3b, b) explore the isoform specific functions of Gsk3a vs Gsk3b in hematopoietic cells, and c) investigate the roles of Gsk3a and Gsk3b in the osteoblast niche by crossing conditional Gsk3a/b mice to an osteocalcin specific cre (OC-cre). Aim to be completed in R00 period: Specific Aim 3: Test whether activating Wnt and blocking mTOR expands HSCs in ex vivo culture and screen for novel effectors with similar ex vivo activity: We will test whether the combination of GSK3 and mTOR inhibitors allows expansion and/or preservation of the HSC pool ex vivo. We will also perform an RNAi- based loss of function screen (using a commercial shRNA library) for new genes/factors that control the expansion and maintenance of HSC ex vivo. 1